Mechanism of lysyl oxidase propeptide in oral squamous cell carcinoma microenvironments

Oral cancer is the 6th most common cancer, mostly tongue oral squamous cell carcinoma (OSCC). Surgery and
radiation treatments result in severe quality of life issues, tissue stiffness and metastasis. Lysyl oxidase (LOX)
is one of five paralogues. All catalyze the final extracellular enzymatic reaction required for collagen biosynthesis.
Only LOX undergoes biosynthetic processing to release the active enzyme and the unique 18 kDa lysyl oxidase
propeptide (LOX-PP) that inhibits tumor growth. Preliminary data show that a polymorphic point mutation in the
LOX-PP region of LOX gene leading to R to Q amino acid change in LOX-PP is linked to increased OSCC. We
further show that wildtype LOX-PP cross-talks with macrophages to shift phenotype to inflammatory tumor
suppressive cells. In lesion microenvironments in 4NQO induced oral cancer WT mice exhibit tumor suppressive-
T cell markers, while knockin Q LOX-PP (KI) mice show tumor cells. We published that LOX-PP, but not
polymorphic Q LOX-PP, inhibits FGFR signaling, and that LOX-PP can bind directly to FGFR1. In non-oral
cancers immunosuppressive macrophages overexpress FGF-2 and FGFR1 and FGF-2 regulates conversion to
tumor suppressive cells in vitro and in vivo. Interestingly, LOX enzymes from all 5 paralogues can be up-
regulated, including in OSCC, to promote fibrosis. Integrating these findings, we propose that in OSCC
microenvironments, the polymorphic Q LOX-PP has lost its tumor suppressor function via its inability to block
FGFR-dependent macrophage phenotype swich to pro-inflammatory tumor suppressive with consequences on
T cell activation and OSCC outcomes. To investigate the hypothesis that LOX-PP regulation of macrophage
phenotype contributes to OSCC tumor suppression that is lost in Q LOX-PP we propose 3 Aims. In Aim 1a we
will investigate in tumor microenvironments vs adjacent regions macrophage phenotypes and local modulations
of T cell and mesenchymal cell type and gene expression changes utilizing state of the art spatial transcriptomics
technologies in WT compared to KI mice in the 4NQO model of cancer. The 4NQO model mimics human OSCC
development. Pathways will be validated in vitro and in vivo. In Aim 1b we will determine the relative ability of
recombinant WT R LOX-PP vs Q LOX-PP to block oral cancer development in mice. In Aim 1c we will investigate
human cancer tissues for the same pathway differences in clinical samples from oral cancer subjects with WT
and variant LOX genotype. Aim 2a will determine differential effects and regulatory mechanisms of WT vs variant
LOX-PP on macrophages in vitro. In Aim 2b we will perform a loss of function study of secreted FGF-2 KO mice
that may have rescued OSCC response to 4NQO in LOX-PP KI mice. In Aim 2c we investigate the ability of
local wildtype AAV LOX-PP injection in KI mice with or without a LOX enzyme inhibitor (PXS-5505) to determine
additive or synergistic benefits in 4NQO induced OSCC. In Aim 3 we will determine affinity of LOX-PP and Q
LOX-PP to FGFR1 in vitro, and perform structure-function studies, and identify functional direct LOX-PP binding
partners. Data will provide functional targets of LOX-PP in oral cancer tumor suppression.

Public health relevance
Project Narrative We recently found that a naturally occurring inherited change of one amino acid in an extracellular matrix protein called the lysyl oxidase propeptide (LOX-PP) results in worse oral cancer outcomes in people. Here we propose to investigate why the variant LOX-PP, unlike the more common LOX-PP, fails to bind to and regulate how a cell surface protein known as FGFR1 results in an immune cells including macrophages to control other immune cells and mesenchymal cells to promote cancer. Understanding molecular interactions between LOX- PP and FGFR1, and how this interaction controls how tumor cells, immune cells, and bystander cells communicate will help us to come up with new strategies to help control oral cancer.